Cortico-hippocampal circuit dysfunction in an Scn1a mouse model of epilepsy

PROJECT SUMMARY
This mentored career development award proposal describes an integrated training program to prepare me to
lead an independent R01-funded biomedical research laboratory focused on the study of epilepsy.
Candidate: I am an Instructor and Research Fellow in the Department of Neurology at the Hospital of the
University of Pennsylvania (Penn). I am a board-certified neurologist and a circuit neuroscientist with expertise
in the technique of optogenetics, gained through my PhD in the laboratory of Dr. Karl Deisseroth. This proposal
is designed to fill my gaps in expertise in experimental epileptology and in state-of-the-art large-scale imaging
methods in brain slice and in vivo. My long-term goal is to use pre-clinical mouse models of epilepsy to motivate
development of mechanistically oriented therapies to transform patient care.
Environment: I will have dual-mentorship from Dr. Goldberg (primary mentor) and Dr. Jensen (co-mentor and
senior career mentor), who have together successfully co-mentored my NIH NINDS R25 research fellowship.
Dr. Goldberg is an Assistant Professor of Neurology and Neuroscience at the Children's Hospital of Philadelphia
(CHOP). He is a rising star in the department who has provided me with invaluable hands-on training at the
bench as well as mentorship from the perspective of a successful junior faculty member and physician-scientist.
Dr. Jensen is Chair of the Department of Neurology. She is an outstanding physician-scientist in epilepsy with a
passion for and well-established track record of mentorship. My mentors and I have constructed a mentorship
team and career development plan to guide the execution of the proposed studies and my transition to
independence. Training will occur at CHOP and at Penn, an academically enriching neuroscience community
with extensive resources and opportunities for scientific interaction, including a wide range of available
coursework and multiple ongoing seminar series in neuroscience, neurology, and epilepsy. This application is
supported enthusiastically by the Department of Neurology at Penn.
Research: My preliminary experiments in Dr. Goldberg’s laboratory have identified a profound hyperexcitability
in the cortico-hippocampal circuit within a mouse model of genetic epilepsy (Scn1a+/-), suggesting a circuit-level
convergence with mouse models of acquired temporal lobe epilepsy. The proposed research will identify the
microcircuitry underlying this finding, and will test the hypothesis that this circuit is critical for the generation of
seizures in the temporal lobe. These outcomes will provide novel insights into mechanisms of this important
genetic epilepsy, as well as establishing more broadly a circuit-level pathogenesis underlying temporal lobe-
onset seizures. This mentored career development award will position me to translate the insights gleaned from
basic neuroscience research to inform and motivate future attempts at the targeted treatment of epilepsy.

Public health relevance
PROJECT NARRATIVE Epilepsy is a debilitating chronic disease that affects over 3 million people in the United States, many of whom have ongoing seizures despite optimized treatments. I propose to determine the mechanism and consequences of a dysfunctional neuronal circuit that I have identified in a genetic mouse model of epilepsy, using cutting-edge techniques for the manipulation and recording of defined neurons within the brain. This mentored career development award will fill gaps in my scientific and technical knowledge and skill set, preparing me for a career devoted to development of novel, mechanistic, circuit-based therapies in preclinical experimental models of epilepsy that can be translated to patient care.